In vivo regulation of the extracellular matrix

Summary. Animals are composed of living cells and the 3-diminsional network of molecules that surrounds
them, the extracellular matrix (ECM). In addition to its structural and protective functions, the ECM is an important
regulator of cell organization, differentiation, morphogenesis, and physiology. Previous ECM studies have
focused largely on basement membranes, the ECM that contacts the basal surface of polarized cells. Much less
is known about the apical ECM (aECM), which resides within epithelial, mesothelial, and endothelial lumens and
on the surface of epidermal cells. Recent studies have implicated the aECM in the control of cell shape, tissue
morphogenesis, and tube formation, leading to a new appreciation of aECM impacts on development and
disease. At present, little is known about the regulation of the aECM, including the pathways that control its
deposition, organization, and remodeling. The proposed studies will address these gaps by investigating aECM
regulation in two distinct contexts: C. elegans (1) embryonic morphogenesis and (2) larval molting. These
separate lines of investigation recently converged with the discovery that intracellular trafficking factors play a
crucial role in aECM regulation at both stages. In the case of embryogenesis, two conserved but previously
uncharacterized proteins, SYM-3/FAM102A and SYM-4/WDR44, enable the nascent epidermis to resist
deformation by biomechanical forces. Current data suggest that SYMs partner with multiple endocytic factors,
including RAB-11, to control trafficking and aECM integrity. In the case of larval molting, conserved members of
the NEK family of protein kinases, NEKL-2/NEK8/9 and NEKL-3/NEK6/7, are required at each molt to facilitate
remodeling of the cuticle, an aECM derived from the epidermis. Current data indicate that NEKLs regulate
trafficking in close association with AP2, a core component of clathrin-coated vesicles, and through the control
of endocytic actin. Future studies on SYMs and NEKLs will combine genetics, cell biological, biochemical, and
omics-based approaches to understand their specific functions in trafficking and to link these activities to effects
on the aECM. To broaden impact, analyses will incorporate mammalian cell culture systems, as current data
indicate that NEKL and SYM functions are conserved. Beyond elucidating aECM biology, these investigations
will characterize mechanisms of apical trafficking, which is poorly understood and differs substantially from
endocytosis at non-polarized or basolateral membranes. Work on NEKLs will also address the role of
phosphorylation in regulating components of the endocytic machinery, which is thought to be pervasive but
remains largely uncharacterized. Moreover, whereas the vast majority of trafficking studies have used in vitro
cell culture systems, work on the NEKLs and SYMs will take advantage of the ability to study trafficking within
an intact developing organism. Finally, proposed studies will yield insights into the roles of trafficking, signaling,
and ECM remodeling in nematode molting, an understudied process with relevance to human biology and health.
Collectively, this work will impact the fields of intracellular trafficking, ECM biology, signaling, and development.

Public health relevance
Project Narrative The complex protein-based network that surrounds living cells, the extracellular matrix, is in many ways as important to organismal development and health as the cells themselves. Produced and continually modified by the underlying cells, the extracellular matrix provides structural support and conveys a wide range of information affecting nearly all aspects of cell behavior. Our studies seek to identify and characterize the genes and cellular processes responsible for generating, maintaining, and modifying this matrix, thereby revealing underlying mechanisms governing human development and disease.